Einstein/Rwanda/DRC Consortium for Research in HIV/HPV/ Malignancies

PROJECT SUMMARY
Sub-Saharan Africa carries a disproportionate burden of HIV, with 69% of infections globally, as well as a high
burden of virally induced malignancies, even before the HIV epidemic. Currently a third of all cancers in Sub-
Saharan Africa are virally induced. While data from Africa are scant, evidence from other parts of the world
indicates that with increasing rates of treatment with combination antiretroviral therapy for persons living with
HIV (PLWH), the incidence of HIV-associated malignancies (i.e., Kaposi’s Sarcoma, non-Hodgkin’s
Lymphoma) has declined dramatically. However, cancers caused by human papillomavirus (HPV), specifically
invasive cervical cancer and anal cancer, have not declined and may have increased.
Investigations of HPV-related malignancies are heavily dependent on laboratory testing and histopathology,
which can be implemented in resource limited settings. The Rwanda/DRC/Einstein HIV-Associated HPV-
Malignancies Research Center (HAMRC) proposed in this application will extend both the geographic and the
scientific scope of our research and capacity-building activities. We will leverage our existing HIV research
partnerships in the Democratic Republic of Congo (DRC) to include much desired research capacity to assess
HPV-related cancers in PLWH.
The Center proposes major studies of HPV-related malignancies through two projects: 1) evaluating the impact
of HPV prophylactic vaccination in young women living with HIV; and 2) assessing HPV infection and disease
in Congolese (DRC) and Rwandan men who have sex with men with and without HIV infection. In both studies
we will investigate the interactions of HPV infection and disease with the local microbial flora. The Shared
Resources Core addresses the goal of the HAMRC by fostering sustainable research capacity in Rwanda and
the DRC to support investigation of viral-associated cancers. Thus, the specific aims of the Shared
Resources Core are to provide rigorous molecular diagnostic analyses to support studies of the impact of both
HAMRC projects, and to increase capacity to conduct research in HPV-related malignancies in PLWH in
Rwanda and the DRC, and will specifically:
1. Replicate in the Pathology Laboratory at Université Protestante au Congo, the real-time PCR platform
for hrHPV typing previously established at Rwanda Military Hospital (RMH), in the Einstein/RMH
Research Laboratory.
2. Develop at the Rwanda Military Hospital (RMH), in the Einstein/RMH Research Laboratory, and in
collaboration with the University of Rwanda, next generation sequencing.
3. Support further development of ELISA testing in Rwanda, at the Einstein/RMH Research Laboratory,
using an assay to measure anti-HPV16 and HPV18 IgG antibody titers implementing a protocol
established by the Frederick National Laboratory of Cancer Research HPV Serology Laboratory.
The proposed capacity building will include personnel development of both research staff and investigators and
will efficiently leverage existing research infrastructure previously developed in large part by the efforts of the
proposed HARMC leadership.

Public health relevance
PROJECT NARRATIVE Sub-Saharan Africa carries a disproportionate burden of HIV and a high burden of virally induced malignancies. Investigations of HPV-related malignancies are heavily dependent on laboratory testing and histopathology, which can be implemented in resource limited settings. The Rwanda/DRC/Einstein HIV- Associated HPV-Malignancies Research Center (HAMRC) proposed in this application will extend both the geographic and the scientific scope of our research and capacity-building activities, in part by developing a Shared Resources Core to support high risk HPV typing and next generation sequencing-based microbiome analysis.